Laboratory Services Section, Department of Transfusion Medicine Core Report

This Core Report summarizes the publications from the Laboratory Services Section (LSS) of the Department of Transfusion Medicine (DTM) in the NIH Clinical Center. All reports that were published to date since 2019 by LSS are included, as long as they are not covered in other NIDB reports from this section. The list comprises collaborations with NIH Institutes, the FDA, and non-government institutions. It includes original research contributions, committee reports, reviews, commentaries, and editorials, along with studies supported by transfusion medicine resources within LSS.